FY25 AWARD. NIDA DEVELOPMENTAL STUDIES BIOREPOSITORY AND ANALYSIS CENTER. SEPTEMBER 17, 2025 - SEPTEMBER 16, 2026. N01DA-21-5588. TASK ORDER 75N95025F00001 (TO5).

This contract supports work that is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. The NIH HEAL Initiative bolsters research across NIH to improve treatment for opioid misuse and addiction.